Renewal: MIRA: Epigenetic regulation of genome integrity, environmental interaction, and inheritance

PROJECT SUMMARY
The Project Summary is contained within the Research Strategy.

Public health relevance
PUBLIC HEALTH RELEVANCY STATEMENT / NARRATIVE Epigenetic modifications (the layer of chemical information sitting on top of the genome) that switch genes ‘on’ or ‘off’ play critical roles in many biological processes, including genome expression, genome integrity, development, environmental responses, and diseases. Its correct deposition and maintenance are critical for the development and function of cells, tissues, and organisms and are often disturbed in developmental disorders and diseases. The proposed research programs are relevant to public health because in-depth mechanistic knowledge of epigenetic regulation will lead to the development of innovative tools to correct aberrant epigenetic modifications and ultimately enable new applications for medicine and human health.